A multiplexable in vivo perturbation toolkit to identify genes affecting neurodegeneration in a model of synucleinopathy

Neurodegenerative disorders such as Alzheimer's disease (AD), Parkinson's disease with dementia (PDD)
and dementia with Lewy bodies (DLB) have no cure, but all three share signs of α-synuclein (α-syn) pathology
and a pattern of neurodegeneration in which there is variation in neuronal loss. Our long-term goal is to
examine this differential neuronal susceptibility to identify features of neurodegeneration in synucleinopathy,
and to use this knowledge for subsequent development of neuroprotective strategies and biomarkers. Our
central hypothesis is that CRISPR-Cas9 library screening can be used as a cell-type specific, high-
throughput in vivo method to elucidate determinants of neurodegeneration in synucleinopathy. The rationale
for the proposed research is that, once susceptibility modifiers are identified, therapeutic strategies can be
devised for the treatment of PDD, DLB and even perhaps AD. Thus, in AIM 1, we propose to begin by
identifying candidate modifiers of neuronal susceptibility in the transgenic mThy1-α-syn (L61Tg) mouse
model of synucleinopathy using cell-type-enriched single-nucleus profiling of dopaminergic (DA) neurons.
Given the known differential susceptibility among ventral midbrain DA neurons in synucleinopathies, we posit
that transcriptomic profiling of these neurons will not only identify signatures of neuronal resilience to stress,
but also identify candidate modifiers for inclusion in our subsequent CRISPR library screen. For this work,
our cell-specific nuclei tagging system will allow to selectively profile, by single-nucleus RNA-sequencing, DA
neurons in L61Tg and their non-transgenic (NTg) littermates. The resulting sequencing data will then be
clustered and investigated using differential composition and gene expression analysis to generate a final
set of candidate genes that are expressed in subsets of DA neurons, differentially regulated in L61Tg mice,
and relevant to human DA subtypes. These candidate genes, which will be included in the list of perturbation
candidates in AIM 2, will also serve as a set of genes for future investigations in neurodegeneration research.
Next, in AIM 2, we will perform a targeted in vivo CRISPR library screening of DA-neurons in the same mouse
model of synucleinopathy. Here, single guide RNA (sgRNA) libraries will be delivered by systemic AAV
injection, before brains are harvested six months later and processed for sgRNA sequencing, to identify which
genes from our list, upon being silenced, are functional modifiers of neuronal loss. The candidate gene list
will be made of our reported hits (Brichta et al., Nat Neurosci, 2015) and those identified in AIM 1. Successful
completion of this project will reveal determinants of neuronal survival in vivo and in response to α-syn, a
stressor relevant to human neurological disorders. Thus, our anticipated results will have an important
positive impact as they will provide opportunities for preventive and therapeutic interventions and,
fundamentally, advance our mechanistic understanding of PDD, DLB and even perhaps AD.

Public health relevance
Why some cells die while other survive in the brains of patients with synucleinopathies remains uncertain. Herein, we propose to use a new gene editing technology to elucidate the mechanisms driving cell resilience in these neurological disorders. If successful, this strategy may have far-reaching implications for the treatment of synucleinopathies and even perhaps Alzheimer's disease.